Core B: Recruitment and Sample Collection

Abstract – Recruitment and Sample Collection Core B
Core B will be responsible for recruitment and sample collection for the RESPOND cohort to provide the
necessary data and biological specimens for all of the Projects. The Core will recruit the RESPOND cohort of
10,000 AA men with PCa diagnosed between 2015-2018 and provide survey data on social stress and linkage
geocoded indicators for Project 1, saliva for germline DNA extraction for Project 2, and tumor tissue for
Projects 3 and 4. The data and biospecimens obtained from this cohort will provide unprecedented insights
into factors associated with PCa aggressiveness in AA men. More specifically, the Core will coordinate
recruitment among 9 cancer registry sites in 7 states, providing instructions for sample selection to assure the
necessary distribution of African American (AA) prostate cancer (PCa) cases by clinical characteristics and risk
groups, the development and pretesting of a brief baseline survey in an optically scannable format,
development and standardization of protocols for initial contact and follow-up with cases to meet response rate
goals as well as a second contact to obtain saliva samples, HIPAA forms, and tissue blocks. Protocols for
handling and delivery of saliva and tissue samples to Core C and data from the survey, registries and external
linkages to Core D will also be coordinated. The Core will provide printed surveys, brochures and newsletters
to the sites and contract for optical scanning of survey responses and external data linkages (for Project 1).
The importance of centralizing the coordination of recruitment and sample collection by the Core is a critical
need for the Program Project. With multiple recruitment sites, the standardization of protocols will be essential
for assuring comparable data collection and recruitment across sites. Also, the Core will monitor the progress
of the recruitment effort through weekly conference calls and will be able to identify problems and address
them in a timely manner to assure that the goals of the Program Project are being met. In addition, the regular
communication among the registry sites will provide information sharing on methods that can improve
productivity for all of the sites. Thus, the Core will enhance efficiencies, standardization and data quality for the
entire Program Project.

Public health relevance
Project Narrative – Recruitment and Sample Collection Core B Core B will be integral to all of the Projects of the Program Project, since it will recruit the men for the RESPOND cohort and provide the study materials used by each, including survey data and external linkages for Project 1, saliva for germline DNA for Project 2, and tumor tissue for Projects 3 and 4. The Core is essential for standardization of procedures across 9 recruitment sites and will strictly monitor study progress to assure that goals are met.